Increasing naloxone availability and use in high-risk settings: public libraries as partners for reducing opioid overdose mortality

PROJECT SUMMARY/ABSTRACT
Opioid overdose mortality has increased substantially since the start of the COVID-19 pandemic. Opioid
overdose deaths are preventable and can be reversed with the timely receipt of naloxone. To date, naloxone
distribution and implementation programs have targeted traditional first responders (e.g., EMS) as well as
people with opioid use disorder and their social networks. While these initiatives have resulted in measurable
reductions in opioid overdose mortality, major gaps in naloxone availability and use persist. The overarching
goal of this work is to save lives by advancing evidence regarding place-based naloxone
implementation and overdose reversal readiness in high-risk settings, using public libraries as a test
case. More than one in ten public libraries experienced an on-site overdose in 2022. In addition, public
libraries—which host 1.2 billion in-person visits annually and are within 2 miles of most Americans’
homes—are an important safety net for vulnerable populations, including those with substance use disorders.
For these reasons, libraries represent a novel setting to promote naloxone uptake. There have been nascent
efforts to equip libraries with naloxone, however, uptake remains low. Thus, we aim to understand institutional
barriers to and facilitators of naloxone uptake (Aim 1). Then, we will establish a Public Libraries Cohort (PLC)
to monitor and identify drivers of naloxone uptake and incidence and outcomes of overdose among public
libraries (Aim 2). Aim 3 will compare the efficacy of two web-based interventions (facilitator-guided and
self-guided training), each vs. the other and vs. usual care, on increasing both overdose reversal readiness
and naloxone uptake in libraries. This work will advance the evidence for place-based naloxone
implementation and overdose prevention.

Public health relevance
PROJECT NARRATIVE Naloxone availability is a cornerstone of the public health response to opioid overdose, which claimed more than 80,000 U.S. lives in 2021. While current approaches to naloxone implementation have focused on distribution of the medication to traditional first responders and people at high-risk, the proposed work will advance place-based strategies for naloxone implementation in public sites of drug use and overdose. The proposed aims will be pursued with public libraries—12% of which experienced overdoses in a single year.